INTRON-A (INTERFERON ALFA-2B) IN SYSTEMIC MASTOCYTOSIS

To assess the effects of Intron-A in ten patients with an established diagnosis of systemic mastocytosis unresponsive to conventional treatment.